Together: Transforming and Translating Discovery to Improve Health

Contact PD/PI: Nelson, David R
Overall Abstract
ABSTRACT
Florida is a demographically and geographically diverse state. The University of Florida (UF) and Florida State
University (FSU) CTSA hub will work within this environment to further the mission to improve human health by
accelerating the translation of scientific discoveries and the implementation of evidence-based best practices
for the diagnosis, treatment, prevention and cure of human diseases across the lifespan. The UF-FSU hub
vision is “think globally, act locally”, offering research opportunities to underserved participants in North and
North Central Florida, creating innovative career development and training opportunities, as well as
collaborating across the country with the Accelerated Clinical Trials Network and PCORnet. Research
strengths include precision medicine, team science, community engagement, implementation science and
informatics which are conducted in diverse settings through the OneFlorida Clinical Research Consortium. The
2019-2024 period represents the next phase of evolution from creating a clinical and translational science
infrastructure to enhancing the local, state and national impact of CTSI-led science. During this period, FSU
will be integrated across all components and will engage six additional colleges. Hub activities will be centered
around four strategic goals: (1) chart new pathways for developing the translational workforce by taking UF’s
success in career development and translating this success to the FSU and historically black colleges and
universities; (2) strengthen the capacity of the learning health system environment and develop transferable
models for embedding translational science into the clinical enterprise by further integrating data and software,
developing multi-site pilots in healthcare institutions serving unique patient populations and building on the
success of the personalized medicine program to use genomics data to improve patient outcomes; (3) expand
statewide collaborations and opportunities to advance a participant-centered research agenda that reflects the
health priorities and diversity of the catchment area by continuing to strengthen stakeholder engagement and
trust in research through the HealthStreet Program and enhance collaboration with policy stakeholders from
Florida Medicaid, Florida surgeon general and others; and (4) strengthen regional and national collaborations
to accelerate the collective impact of the CTSA network through continued work with ACT, PCORnet, genomic
medicine, aging and metabolomics. Throughout this important work, the UF-FSU hub will remain dedicated to
supporting the recruitment, retention and career development of underrepresented minority and disabled
trainees and faculty. Integral to the success of the proposed work, the UF-FSU hub will further integrate health
care and research in Florida guided by four keys to success: (1) organizational alignment, (2) clinical
informatics, (3) clinician and stakeholder engagement, and (4) strong support from implementation and
improvement science expertise.
Page 415
Project Summary/Abstract
Contact PD/PI: Nelson, David R
Overall Narrative
NARRATIVE
The University of Florida (UF) and Florida State University (FSU) CTSA hub will work within the
demographically and geographically diverse state of Florida to improve human health by accelerating the
translation of scientific discoveries and the implementation of evidence-based best practices for the diagnosis,
treatment, prevention and cure of human diseases across the lifespan. The 2019-2024 period represents the
next phase of evolution from creating a clinical and translational science infrastructure to enhancing the local,
state and national impact of CTSI-led science with a special emphasis on underserved and unique patient
populations.
Page 416

Public health relevance
The University of Florida (UF) and Florida State University (FSU) CTSA hub will work within the demographically and geographically diverse state of Florida to improve human health by accelerating the translation of scientific discoveries and the implementation of evidence-based best practices for the diagnosis, treatment, prevention and cure of human diseases across the lifespan. The 2019-2024 period represents the next phase of evolution from creating a clinical and translational science infrastructure to enhancing the local, state and national impact of CTSI-led science with a special emphasis on underserved and unique patient populations.